BRAIN Viral Vector Services and Distribution Core

The BRAIN Viral Vector Service and Distribution Core will serve as a resource for the maintenance,
propagation, and distribution of viral vectors that are used by neuroscientists for neural circuit
identification and manipulation, as well as for preclinical translational studies. High-quality viral
vectors are essential tools to mark and manipulate neuronal circuits in live animals and identify long-
range synaptic connections. Moreover, adeno-associated virus (AAV) vectors are the de facto
standard for gene therapies. Existing commercial viral vector sources do not offer end-to-end
services, from assisting with viral vector design, rigorous manufacturing and quality controls,
troubleshooting with clients to enhance vector performance in the brain, and a mission focused on
neuroscience. The Core Director (Dr. Kim Ritola) will translate her ten years of providing viral tools to
the Howard Hughes Medical Institute neuroscience community towards creating a BRAIN Viral Vector
Service and Distribution Core capable of producing and distributing AAV, rabies, and lenti virus tools
to neuroscientists. The Core will have two main purposes: 1) Produce and disseminate affordable,
high-quality AAV, rabies, and lenti viral vectors to the neuroscience community including newly
developed vectors, custom preps and curated stocks and 2) Collaborate with BRAIN researchers to
optimize vector design and prep conditions for optimal performance and serve as an educational
resource for viral vector production. This Core will provide investigators with an extensive choice of
vector capsid or envelope, paired with custom viral construct, including those with traditionally difficult
to package genomes, titers and volumes appropriate for experiment type, rigorous quality controls,
and affordability.

Public health relevance
Neuroscientists commonly use viral vectors as tools to evaluate how diverse brain cell types function and interconnect in animals and in models of neurological, neurodevelopmental, and neurodegenerative disorders. Moreover, viral vectors are increasingly being used to shuttle replacement genes and other molecules into brain cells to treat brain disorders. The BRAIN Viral Vector Service and Distribution Core will serve as a national resource for the distribution of high- quality viral vectors tailored specifically to neuroscientists working on topics relevant to the BRAIN Initiative and enable neuroscientists to pioneer new viral vector-based treatments for brain disorders.